Administrative Core

CORE A - ADMINISTRATIVE CORE - ABSTRACT The goal of the Administrative Core is to coordinate regular communication among all the Project Investigators, plan the periodic meetings of the investigators and the External Advisory Committee, prepare progress reports and grant renewals, and maintain financial accounting between the home institution (Wisconsin), the other participating institutions (Rochester and Brigham and Women's Hospital), and the NIH. An administrative assistant manages day-to-day Program business. This person will be responsible for grant accounting at Wisconsin, coordination with the consortium sites on grant accounting and regulatory compliance issues, collection of updated materials for progress reports and grant renewals, and coordination of biannual meetings of Project Investigators and the annual meetings with the External Advisory Committee. The administrative assistant also acts as liaison between the Program Director, Project Investigators and NIH grant management personnel. An Internal Advisory Committee (composed of senior administrative officials from each of the participating institutions) will advise on resolution of potential conflicts.